Administrative Supplements for P30 Cancer Centers Support Grants (CCSG) to Enhance the Utility of Data Available through the Childhood Cancer Data Initiative (CCDI) Ecosystem

Summary
Cancer remains the leading cause of death from disease in children. Development of therapeutic options for the
remaining lethal cancers has seen little progress, hampered by the rarity of childhood cancers and institutionally
isolated data systems holding tumor biomarker, genetic, genomic, treatment and clinical data, which impedes
maximally powered therapeutic studies. The National Cancer Institute’s Childhood Cancer Data Initiative (CCDI)
seeks innovation in pediatric cancer research approaches by markedly increasing data-sharing. Under the
auspices of a previous P30 Supplement award, the USC Norris Comprehensive Cancer Center (NCCC) in
partnership with Children’s Hospital Los Angeles (CHLA) successfully curated and contributed to CCDI genomic
and clinical data of 1039 patient of three major categories (hematopoietic malignancies, solid tumors and CNS
tumors) and 186 subtypes. We now propose to enrich the data sets that we submitted and to develop an online
diagnostic resource for pediatric cancers driven by augmented Artificial Intelligence (A2I), which aims to improve
pediatric cancer care access and affordability by providing a scalable and standardized diagnostic process. The
proposed A2I system will develop an AI-powered classifier for pediatric CNS and sarcomas, and ultimately all
pediatric cancer, using whole-slide images and molecular findings in combination. Aim 1 will collect whole-slide
image (WSI) from 599 solid tumors and whole-genome methylome data of 200 CNS tumors. Collected WSI and
methylation data of these 599 tumors will be contributed to CCDI and become an integral part of our existing
CHLA CCDI data set. Aim 2 will develop a multi-modal classifier of sarcomas and CNS tumors using an
Augmented AI (A2I) framework. The proposed classifier is entitled Multi-Modal AI-based Diagnosis for Pediatric
Oncology (MAD4PO), which will be cloud-based and web-accessible. To build this classifier, we will leverage
the Amazon Web Services (AWS) A2I framework and associated services and tools to facilitate human-AI
collaboration for optimal diagnostics, and to scale out access to the developed ML/AI models for global
healthcare providers. Work carried out under this supplement will facilitate efforts to understand the biologic
basis of childhood cancers and to develop improved treatment for these diseases, while providing new tools for
more rapid and accurate diagnosis of pediatric cancers.

Public health relevance
Narrative Aggregation and sharing of diverse types of data resulting from scientific studies of childhood cancer is essential for generating new insight and supporting the development of new therapies. Previously, the partnership between Children’s Hospital Los Angeles and the USC Norris Comprehensive Cancer Center resulted in the addition of data from more than 1,000 pediatric cancer patients to the Childhood Cancer Data Initiative. In the current proposal, we outline plans to enrich the CCDI with new types of data including tumor DNA methylation and histopathologic images, and introduce innovative tools for more rapid and accurate diagnosis of pediatric cancers.